Imaging Core

ABSTRACT: IMAGING CORE
The Imaging Core will acquire, analyze, and disseminate positron emission tomography (PET) and
magnetic resonance imaging (MRI) data from participants in the UAB ADRC cohort. Measures will included
amyloid-PET, tau-PET, regional brain volumes for ATN classification and brain MR measures of vascular
disease. A key goal of the imaging core is to obtain and share robust neuroimaging biomarker data relevant to
AD in Black or African American (B/AA) individuals, a population underrepresented in imaging biomarker
studies. These imaging data will be available to investigators at UAB and other institutions to support research
in B/AA populations and to further the understanding of the impact of racial disparities in AD and related
cognitive disorders. PET and MRI data will be acquired in the centrally located UAB Advanced Imaging Facility
using a simultaneous PET/MRI system, processed using a validated semi-automated workflow, and shared
with other investigators through a secure cloud-based platform. Qualitative and quantitative summaries of
image analysis as well as anonymized DICOM data sets will be available to investigators through data use
requests. The Imaging Core will work closely with the Clinical and Data Management and Statistical Cores to
maximize the percentage of the ADRC cohort who participate in molecular neuroimaging and to ensure that
the imaging data for individuals are linked to their clinical assessment, cerebrospinal fluid (CSF) biomarkers,
and other assessments. The Imaging Core will also support investigators who wish to use investigational PET
tracers and MRI techniques for research projects that build upon the ADRC cohort. The Imaging Core will also
support training and educational activities in structural and molecular neuroimaging for trainees and junior
faculty in neurology, neuroscience, radiology, nuclear medicine and other relevant specialties.